Investigating the roles of UBE3A and TRPML1 in extracellular vesicle regulation to understand Angelman syndrome pathogenesis

Brain development is a complex process involving intricate molecular interactions, which lead to
alterations at the synaptic, neuronal, and circuit levels. Abnormalities in this process result in
various forms of neurodevelopmental disorders. Angelman syndrome (AS) is a rare
neurodevelopmental disorder with severe developmental delay, lack of language skills, severe
cognitive impairment, motor dysfunction, and often with comorbid epilepsy and autism spectrum
disorder (ASD). Genetic/genomic studies have attributed the cause of AS to deficiency of UBE3A,
an imprinted gene, in neurons. Mice with maternal Ube3a deficiency recapitulate most of AS
symptoms, and studies with these mouse models have revealed that Ube3a deficiency affects
many brain regions and circuits. On the other hand, UBE3A overexpression or gain-of-function
mutations have been linked to increased risk for autism spectrum disorders. Thus, accumulating
evidence indicates that UBE3A plays critical roles in brain development and maturation. However,
there is still a critical need for better understanding the roles of UBE3A during development and
in adulthood. Emerging evidence also shows that the lysosomal cation channel, TRPML1, is also
crucial for normal brain development and functions, since its deficiency results in a developmental
neurological disease, muculipdosis type IV (MLIV). In recent years, extracellular vesicles (EVs),
have been shown to play diverse roles in brain development and functions, in health and disease,
through intercellular communication and transport of molecules. The proposed studies will test
the hypothesis that UBE3A regulates dendritic spine development through TRPML1-mediated EV
release, and that UBE3A deficiency leads to reduced EV release, resulting in abnormal dendritic
spine development and maturation. The proposed studies will further test the hypothesis that
treatment with EVs from wild-type neurons could rescue dendritic spine deficiency in AS neurons.
The outcomes of this proposal will not only shed light on the roles of UBE3A and TRPML1 in
neuronal development through the regulation of EV release but also provide novel approaches
for the therapeutic treatment of AS patients. As emerging research indicates that EVs are suitable
biomarkers and potential therapeutical tools for several neurological disorders, the outcomes of
this proposal could have broad clinical implications.

Public health relevance
Recent research has demonstrated that, while deficiency of UBE3A results in Angelman syndrome, increased expression of UBE3A enhances the risk for autism spectrum disorders. Mucolipidosis type IV, another neurological disorder with severe developmental delay and abnormal brain function, is caused by mutations in the gene encoding a lysosomal channel, TRPML1. The proposed studies investigate the roles of UBE3A and TRPML1 in brain development and functions through the regulation of extracellular vesicles. The outcomes of this proposal could have broad clinical implications.